Molecular mechanism of Vasa function in localized mRNA translation on the spindle

PROJECT SUMMARY
Localization of mRNA and its on-site translation (localized translation) enables spatiotemporal
control of protein synthesis in the cell. The mitotic spindle is a sub-cellular region where localized
translation has been reported to occur, yet its mechanism of regulation is largely unknown in any model
system. We previously reported a conserved DEAD-box RNA helicase, Vasa, as a promising factor that
regulates localized translation on the spindle in the sea urchin embryo. At asymmetric cell division, Vasa
asymmetrically localizes on one side of the spindle, which is critical for asymmetric translation and the
formation of micromeres, a major signaling center in the embryo. The preliminary results suggest that the
predicted Vasa's target mRNAs are maternally loaded. Further, transcription is scarce during early
embryogenesis. Therefore, we hypothesize that Vasa recruits and unlocks the maternal mRNAs for
translation on the spindle, providing spatiotemporal control in protein synthesis during embryogenesis.
To test this hypothesis, Question 1 will identify Vasa's target mRNAs and their functional
contributions to mitosis. As a preliminary study, we computationally predicted several of Vasa's target
mRNAs, which all appear to be involved in mitosis. We will identify how Vasa is critical for these targets'
localized translation on the spindle and how they contribute to mitosis by real-time imaging of translation
in developing embryos. Further, we will perform APEX-seq to comprehensively identify Vasa's target
mRNAs on the spindle, followed by experimental validations of the obtained data.
Question 2 will reveal the significance of Vasa-mediated asymmetric translation to embryonic
development. Using optogenetics, we will deplete Vasa specifically at the 16-cell stage when micromeres
are formed. We will process the resultant embryos at the 16-cell, morula, and blastula stages for single-
cell (sc)RNA-seq, followed by experimental validations of the obtained data. The resultant data will
identify what mRNAs Vasa asymmetrically recruits and translates in micromeres at the 16-cell stage and
how its depletion blocks micromeres' signaling function, casing developmental defects at later stages.
Question 3 will identify how Vasa selects its target mRNAs for localized translation. Preliminary
results suggest that Vasa may recruit mRNAs with Guanine quadruplex (G4) secondary structure. Using
both endogenous and synthetic G4-mRNA constructs, we will determine the essentiality of the G4 motif
for Vasa's recruitment by real-time imaging of the mRNA. We will also reveal how the G4 motif impacts
the timing and location of Vasa's target mRNA translation by real-time imaging of translation in embryos.
Future steps include identifying Vasa's partners responsible for its granule assembly and how that
controls its target mRNA's localized translation. We will also integrate the obtained omics data into our
current prediction to identify Vasa's conserved targeting mechanism and function across organisms.

Public health relevance
Project Narrative Localized translation on the spindle is an essential biological mechanism that allows fine and rapid control of protein activities at the sub-cellular level. The proposed research identifies how it is regulated and contributes to efficient cellular activity and fate regulation during rapid embryonic development.